Multidisciplinary Training in the Biology of Alcohol Addiction

The renewal of the “Multi-Disciplinary Training in the Biology of Alcohol Use and Abuse” pre- and postdoctoral
training program at Wake Forest University School of Medicine will continue support for five predoctoral and three
postdoctoral trainees. Our objectives remain to broadly train interdisciplinary and independent alcohol
researchers who have a strong appreciation for the molecular, cellular, neurobiological, and behavioral aspects of
alcohol use and abuse. To achieve these objectives, the training faculty utilizes an array of state-of-the-art-
technical approaches and models that include in vitro systems, rodents, nonhuman primates, and human
subjects. Integration of these across the program exposes trainees to diverse, translational research experiences.
Our training faculty also have a strong history of productive mentorship with both predoctoral and postdoctoral
scientists. Their collective expertise, along with the highly-collaborative nature of our training environment,
together serve as the specific rationale for the proposed training. The overall design of the training program
incorporates robust didactic experiences, intensive laboratory training, and extensive professional development
activities that include ethics, teaching experience, grant and manuscript writing, extramural didactic/practical
training, and outreach to the lay public. These are supplemented by a training environment characterized by
numerous seminar programs, journal clubs, and data clubs that are all either directly focused on or tangentially
related to alcohol research. As a condition for appointment/reappointment, all trainees are required to present
abstracts at national meetings, publish peer-reviewed manuscripts, and apply for individual training support
through the NIH, NSF, or private foundations. These professional development activities all sharpen the skills
required for a diversity or post-training positions including both academia and research-related careers. We also
hope to limit the number of support-years each trainee receives to help ensure the brightest, most productive
trainees are appointed to the program. Using these administrative and training approaches, along with an
energetic training faculty, the program has a long history of past success and has trained numerous, nationally
recognized researchers. The proposed training will take place in the Department of Physiology & Pharmacology
within Wake Forest University School of Medicine. The department is well-known for its focus on drug and alcohol
abuse research, providing a remarkably diverse and modern training environment for the program. The institution
is likewise dedicated to the training of the next generation of scientists and hosts a number of professional
development activities that both compliment and synergize with the proposed training. Our preceptors, the
applicant pools, program design, and environment together produce a one-of-a-kind opportunity for the training of
the next generation of alcohol researchers.

Public health relevance
The incidence of alcohol abuse remains high in the United States. This training program will supply the United States with highly trained scientists who are poised to address the serious problems presented by alcohol abuse disorders.